Strengthening capacity of researchers in Uganda to conduct HIV treatment and prevention clinical trials in perinatal, paediatric, adolescent, and at risk populations including women and their partners

Project Summary: There has been steady progress over the past 3 decades in both HIV treatment and
prevention based on clinical trials leading to major breakthroughs in pediatric and maternal HIV treatment; and
HIV prevention among at-risk women and adolescent females. These include new interventions with long acting
ARVs for both treatment and prevention. However, there are unique aspects to the conduct of HIV clinical trials
in perinatal, pediatric, adolescent and at risk populations including regulatory/ethical considerations; counseling
approaches; assessing safety, dose finding and pharmacokinetics of new HIV therapeutics in these populations;
which require specific training and practicum experiences. The MU-JHU Research Collaboration/MU-JHU Care
has over 30 years’ experience conducting HIV perinatal and pediatric treatment trials; and more recently, HIV
prevention trials among at-risk adolescent and young women. Thus MU-JHU is well positioned to be a Centre
of Excellence to train other Ugandan researchers/research teams to carry out HIV clinical trials in these
populations; and to further strengthen its own research capacity, with doctoral level behavioral and biostatistics
expertise.
Toward the goals of training other Ugandan researches/research teams in conducting perinatal, pediatric and
adolescent HIV treatment and prevention trials; and of increasing MU-JHU’s biostatistics and behavioral
research capacity, MU-JHU proposes with this D43 application training program to serve as a training center
to offer short term, and medium term didactic and practicum trainings; and support long term training addressing
the unique aspects of conducting HIV perinatal, pediatric, adolescent and adult treatment/prevention clinical
trials. The specific AIMS of this D43 application are:
1) Offer short term (<3 months) training to MU-JHU and other Ugandan research teams on the unique
aspects of conducting HIV clinical trials among pregnant women, pediatric/ adolescents, at risk women
and partners including ethic issues, pharmacokinetics/ safety and trial design.
2) Provide core didactic and practicum medium term 3-6month) training for MU-JHU and other Ugandan
researchers on conducting HIV related clinical trials-- emphasizing the unique aspects of implementing
trials in these populations.
3) Support long term training for doctoral degrees in biostatistics, pharmacology and behavioral topics
relevant to perinatal, pediatric, and adolescent HIV prevention and treatment trials.
4) Provide postdoctoral fellowship research support to early career Ugandan investigators for
research supporting HIV treatment and prevention studies among pregnant women, children,
adolescents and at-risk women and their partners.

Public health relevance
Project Narrative: MU-JHU Research Collaboration/MU-JHU Care LTD in Kampala Uganda seeks to strengthen the capacity of Ugandan researchers to conduct rigorous HIV clinical trials among perinatal, pediatric, adolescent, and at-risk women and partners by supporting innovative short, medium, and long-term training opportunities that address the unique aspects of conducting HIV treatment and prevention trials in these populations. These essential skills and capacity building will include short-term (< 3 months) training for research teams; technical skills through medium term (3-6 months) didactics and practicums; and highly specialized long- term courses (> 6 months). Trainings will be available for suitable doctoral and postdoctoral candidates, and research team staff from MU-JHU and other Uganda research institutions, with MU-JHU serving as the training hub.